Central vs. Peripheral Mechanisms of Headache: Cortex, Thalamus, Dorsal Horn

The mechanisms of migraine are poorly understood, but a large body of indirect evidence has implicated the
nociceptive sensory innervation of the cranial meninges as playing a critical role in the generation of the
headache. A key finding, in single-unit recording studies, was the prolonged activation of the 1st- and 2nd -order
neurons of this meningeal sensory pathway following the induction of cortical spreading depression (CSD), the
cortical phenomenon that underlies the migraine aura. However, there is a fundamental gap in understanding
the neural basis for the perceptual effects of CSD, and the putative role of the meningeal sensory pathway in
these effects: as yet there has been no study of CSD’s effects on the 3rd-order meningeal sensory neurons in
the thalamus, the structure that serves as the gateway to sensory cortex. This is particularly critical because
the thalamus stands apart from the trigeminal ganglion and the dorsal horn (containing the 1st- and 2nd-order
neurons) in 1) its extremely strong reciprocal connectivity with the cortex, and 2) in containing populations of
neurons bilateral receptive fields (in addition to those in the ventrobasal complex with unilateral receptive
fields), whose activity would be critical in clarifying the long-standing problem of the laterality of the migraine
headache and its relation to the laterality of the aura (see Significance).
In addition, this information is relevant to the ongoing question in headache research of to what degree
migraine is a result of processes in the central vs peripheral nervous system. Arguments for a central
mechanism for the generation of the headache have focused on the possibility that CSD might activate the
central neurons of the meningeal sensory pathway through central mechanisms that are independent of
peripheral activation. Such a finding, of activation of a central nociceptive pathway through a central
mechanism, has long been hypothesized but has not yet been demonstrated to occur, in any pain pathway.
We explore these questions in the following two aims:
Aim 1: Characterize the effect of CSD on the activity on thalamic neurons that receive peripheral sensory input
from the cranial meninges, using single-unit recording in anesthetized male and female rats.
Aim 2. Test the hypothesis that the activation of 2nd- and 3rd-order neurons in the meningeal sensory pathway
by CSD can occur independent of peripheral input. These experiments will investigate the peripheral vs central
contribution to the CSD-induced responses.
These studies will have impact on our basic understanding of headache in relation to the key questions,
fundamental to current migraine research, of the sensory perceptual effects of CSD and the contribution of
peripheral vs. central mechanisms to the migraine headache. More broadly, the finding of activation of
nociceptive neurons by a central process that is independent of peripheral input would be a novel finding in the
study of pain mechanisms.

Public health relevance
PROJECT NARRATIVE In spite of the development of new treatments, we still have only a poor understanding of the mechanisms of migraine. One basic question is whether the headache phase of migraine depends on processes occurring in the peripheral or the central nervous system. Clarifying this question has the potential to alter the focus of treatment as well as drug development to central targets in combination with peripherally acting drugs.